Evolutionary Mechanisms of Enhanced Environmental Stress Resistance

PROJECT SUMMARY
Cellular responses to environmental stressors (e.g., hypoxia, metals, and oxidants) are essential
to animal performance and their dysregulation is associated with blindness, cancer, and aging.
These responses are mediated by protein-level mechanisms regulating cytoprotective programs
essential to animal survival. However, the majority of our knowledge into these proteins stems
from human and mouse systems, ignoring the rich diversity of animal specialists —such as fishes,
whales, and birds—that have evolved to survive chronic hypoxia and oxidative stress. This limits
our understanding of the organismal stress response, as well as our ability to modulate these
pathways in novel and unanticipated ways. With hundreds of these animals now represented by
high-quality genomes, my goal is to harness evolutionary adaptation to identify novel molecular
mechanisms modulating the environmental stress response. I recently demonstrated the
enhanced NRF2 stress response of birds, pinpointing the protein-level mechanisms responsible.
Since then, I have produced strong preliminary data identifying additional novel mechanisms in
avian NRF2, as well as equine NRF2 and HIF-1 stress responses—species adapted to
environmental oxidants, metals and chronic hypoxemia. We have identified substantial overlap of
these adaptive mechanisms with those implicated in human diseases, suggesting these animals
have evolved additional compensatory mechanisms. My vision is to reverse engineer these
animal systems to reveal novel strategies capable of modulating the NRF2 and HIF-1 axis in
human diseases where they are dysregulated. Thus, my plan over the next five years is to dissect
these systems with a range of interdisciplinary techniques. Through a research strategy that
integrates diverse perspectives from evolutionary biology, biochemistry, and cell biology, my
program will address major gaps in our understanding of how stress response pathways operate
in natural systems. Thus, my work is well-poised to improve our understanding of human health
by harnessing the molecular strategies ‘discovered’ by natural selection millions of years ago.

Public health relevance
Project Narrative Hypoxia, oxidants, and metals are environmental stressors that cause cellular death and dysfunction. We have discovered that birds and horses possess an enhanced cellular resistance to these stressors, mediated by novel molecular mechanisms. This proposal will allow us to characterize these adaptations, which could identify novel therapeutic strategies to modulate these pathways when they are disrupted in human diseases.